A Foundational Resource of Functional Elements, TF footprints and Gene Regulatory Interactions

PROJECT SUMMARY
This project aims to assemble a foundational resource of functional DNA elements, transcription factor (TF)
binding sites and gene regulatory interactions for the Impact of Genomic Variation on Function (IGVF)
consortium. The resource will facilitate interpretation of noncoding genetic variation associated with human
traits and diseases, advance understanding of disease mechanisms and hasten progress towards genomic
medicine.
A large majority of genetic variants associated with human diseases are non-coding, which has
hindered their interpretation and utility for understanding disease. Non-coding disease variants are enriched
within promoters, enhancers and TF binding sites. Hence, a compelling hypothesis is that they modulate the
activity of functional elements, TF interactions and gene targets in specific cellular contexts. To interpret the
function of a variant, investigators must determine the element and/or TF that they impact, which gene is
affected, and the cell state in which the effect is manifested. This process is greatly facilitated by genome-wide
maps of functional elements, TFs and regulatory interactions. However, existing resources under-represent
disease-relevant functional elements that are specific to early developmental stages, rare cell states,
physiological responses, genotypes or disease states.
To overcome these limitations, the proposed project will deploy an innovative suite of single-cell assays
to profile RNA transcripts, chromatin accessibility, TF footprints and histone modifications at unprecedented
scale. These assays will be applied to an expansive collection of phenotypically- and genotypically-diverse
BioSamples selected for their relevance to cardiovascular, metabolic, autoimmune, neuropsychiatric and
neurodegenerative diseases. We will acquire >16 million single-cell profiles for thousands of BioSamples that
span cadaveric tissues, surgical specimens, peripheral blood mononuclear cell (PBMC) cohorts, brain
organoids and other innovative experimental models. Integration of this vast dataset will enable us to (1)
annotate millions of regulatory elements and TF motifs; (2) predict gene targets from co-variation of element
accessibility and gene expression across single cells; and (3) identify quantitative trait loci for gene expression
(eQTLs) and chromatin accessibility (caQTLs) from the diverse genotypes represented in our cohorts.
The project will bring together a diverse team of experts in human genetics, disease biology, genomics and
production research. The team will coordinate closely with IGVF colleagues and the DACC in the design,
assembly and integration of this resource. All data will be made freely available and maximally accessible to
the scientific community, with the goal to catalyze human genetics, disease biology and genomic medicine.

Public health relevance
PROJECT NARRATIVE The human genome contains genes that code for the protein machines in cells, as well as millions of regulatory switches that control when, where and how much protein is made. Mutations that alter these regulatory switches underlie a wide range of cardiovascular, metabolic, autoimmune, neuropsychiatric and neurodegenerative diseases. This project will assemble a comprehensive public resource of these regulatory switches and the genes that they control, with the long-term goal to advance human genomics research and personalized medicine.